Central Africa International Epidemiology databases to Evaluate AIDS

Project Summary
As HIV care and treatment programs are implemented throughout sub-Saharan Africa (SSA),
critical advances in research and policy are needed so that care and treatment resources can
be deployed to optimal benefit: decreasing new HIV transmissions, HIV-related morbidity and
mortality, and illness from non-communicable disease (NCD). Coverage of antiretroviral therapy
in the 'Treat All' era varies widely in our region, from 87% in Rwanda to 25% in Republic of
Congo, the lowest coverage among all IeDEA countries in SSA. Our research agenda is
designed to generate actionable knowledge to help close these gaps. Our regional cohort
database includes longitudinal data for 81,183 adults and 11,789 children ever enrolling in HIV
care at 22 sites in Burundi, Cameroon, the Democratic Republic of Congo, Republic of Congo
and Rwanda. We propose to supplement this database with linked cohorts to address a range
of investigations relevant to our region including: 1) leveraging implementation science
approaches to inform strategies aimed at improving HIV prevention, care and treatment
outcomes in the region (Aim 1); 2) conducting in-depth clinical investigations of HIV-related
outcomes and infectious (e.g. TB) and non-infectious (e.g. NCDs) comorbidities (Aim 2); 3)
leading and supporting an innovative multiregional scientific agenda within the larger IeDEA
network (Aim 3); and 4.) providing scientific and career mentoring to early stage investigators
and researchers from Central Africa and from the US (Aim 4). Central Africa IeDEA has a
diverse scientific team with broad and deep expertise in implementation science, epidemiology
and clinical research. We have been highly productive scientifically with >45 publications across
a range of topics, and have continued to foster African leadership and build local research
capacity. Themes in our application include an emphasis on ‘treat all’ policy implementation,
mental health and substance use (alcohol), PMTCT and pediatric and adolescent HIV,
tuberculosis, HIV prevention through PrEP, and NCDs in aging people living with HIV (e.g.
kidney disease).

Public health relevance
Project Narrative Sub-Saharan Africa bears the greatest burden of HIV disease globally, and the Central African region is particularly challenged. Research to define the most effective service delivery strategies in these settings is key to decreasing HIV and comorbidities of aging as causes of illness and death. Our research is critical to guide policy makers and program implementers on service delivery mechanisms to provide most efficient use of programmatic resources and the optimal gain to the public's health.